Targeting protein phosphatase 2A for takotsubo syndrome treatment

Project Summary/Abstract
Takotsubo syndrome (TTS), also known as stress-induced cardiomyopathy or broken heart syndrome, is a
condition characterized by sudden temporary ventricle dysfunction secondary to weakening cardiac muscles.
Despite considerable research, our current understanding of the underlying pathogenesis and pathophysiology
of TTS remains incomplete, thus markedly hindering the development of novel pharmacologic therapies to
prevent major adverse cardiovascular events. This proposal describes a research plan that aims to accomplish
the following two goals at both the basic science and translational levels: 1) gain deeper understanding of the
role of a critical protein phosphatase (protein phosphatase 2A, PP2A) in the pathophysiology of Takotsubo
cardiomyopathies; and 2) develop novel small molecule activators of PP2A for the treatment of Takotsubo
cardiomyopathies. Reversible protein phosphorylation plays a critical regulatory role in a wide variety of biological
processes. The regulation of protein phosphorylation is dictated by the activity of both protein kinases and protein
phosphatases. Although there is a significant understanding of how aberrant kinase activity contributes to human
cardiovascular disease, the regulation and therapeutic potential of phosphatases in this area remains under-
explored. PP2A, a holoenzyme with serine/threonine phosphatase activity, plays a pivotal role in a large array of
cellular processes in mammalian cells. Restoration of PP2A activity has been shown to be of significant
therapeutic value, however pharmaceutically tractable approaches to directly activate PP2A remain elusive. Our
recent observations revealed a marked reduction in PP2A activity in cardiac tissues from isoprenaline-induced
TTS mice, as well as in isoprenaline-treated cardiomyocytes. Furthermore, in a murine model of TTS,
administration of an orally bioavailable small molecule activator of PP2A, strongly mitigated myocardial damage
and improved cardiac function in mice. Additionally, preliminary studies support a role for PP2A in modulating
both ferritinophagy and mitophagy in TTS. Collectively, these observations form the basis for the central
hypotheses for this grant application: (1) Reduced PP2A activity is involved in the development of acute heart
failure in TTS and (2) Reactivation of PP2A may serve as a novel therapeutic strategy to prevent/reverse TTS
pathology. Studies in this proposal are designed to extend this new field of cardiac research to gain in-depth
understanding of the function of this phosphatase in cardiac biology. The results will greatly enhance our
understanding of the molecular and cellular processes involved in the progression of acute heart failure in TTS,
potentially paving the way for new therapeutic approaches.

Public health relevance
Project Narrative Takotsubo syndrome accounts for up to 4% of cases presenting as acute coronary syndrome, and incidences continue to rise. Through extensive experimental studies in animals of Takotsubo syndrome, this proposal aims to provide direct support for the preclinical development of a PP2A activator strategy for the treatment of acute heart failure. Additionally, our efforts will also provide novel insights into the pathologic mechanisms of acute heart failure and offer new tools for the investigation of cardiovascular disease.